DREAMS - Admin Core

Abstract/Project Summary: Administrative Core
The Diabetes Research for Equity through Advanced Multilevel Science Center for Diabetes
Translational Research (DREAMS-CDTR) activity is overseen by its Administrative Core, which coordinates
and manages all Center activities across its Translational Research and Resource Cores. The role of the
Administrative Core is to 1) ensure the scientific productivity and collaboration of DREAMS Center Core faculty
members through support and oversight of the translational research and resource cores, as well as the pilot
and feasibility and enrichment programs; 2) encourage collaboration between the DREAMS Center members,
the CDTR and Diabetes Research Centers, and with NIDDK; 3) grow the reach and impact of the center; and
4) review, evaluate, and update Center activities in close collaboration and consultation with the DREAMS
Center Internal and External Advisory Committees.